Stimulus competition and visuospatial selection: Neural circuit and computational mechanisms

PROJECT SUMMARY
Animals routinely operate in complex environments rich in sensory stimuli. They handle this informational
complexity by having their behavior guided by the most salient (and more generally, highest priority) stimulus in
the environment. The neural circuit mechanisms underlying competitive selection of the highest priority stimulus
across space remain poorly understood. Recent evidence from behaving monkeys has revealed that the
intermediate and deep layers of the superior colliculus (SCid), a major sensorimotor hub in the vertebrate
midbrain, are required for normal competitive stimulus selection. In parallel, our work in the barn owl optic tectum
(OTid, avian homolog of SCid) has revealed that OTid neurons signal the highest priority stimulus categorically,
which can account for SCid’s critical role in spatial selection behavior. Such categorical signaling requires a
specialized, donut-like pattern of spatial inhibition onto OTid from an inhibitory nucleus called Imc in the nearby
midbrain isthmic complex. Separately, feedback from a cholinergic isthmic nucleus, Ipc, is known to amplify OTid
firing rates. Despite these insights, several fundamental questions about the functional logic of this isthmo-tectal
(OT-Imc-Ipc) network for competitive stimulus selection remain open, and here, we address three. First, we aim
to elucidate how the preferential neural signaling of the most salient stimulus is implemented in OTid. Specifically,
our hypotheses are (1a) that OTid signals the strongest among competing stimuli with a combination of enhanced
gamma synchrony, reduced trial-trial variability, greater resistance to adaptation, and reduced noise correlations
(rather than just with elevated firing rates), and (1b) that cholinergic Ipc serves as a multiplexed mechanism for
regulating these diverse OTid coding features. Second, we aim to elucidate a neuromodulatory mechanism for
the control of categorization. Our hypotheses (based on our model predictions) are (2a) that (hitherto
uncharacterized) spatially-specific cholinergic input onto Imc neurons causes multiplicative modulation of Imc
activity, and (2b) that it serves as a mechanism to enhance the degree of categorical signaling of the most salient
stimulus by OTid. Third, we aim to uncover the source and broader functional logic of this cholinergic input. Our
hypotheses are (3a) that Ipc is the dominant source of cholinergic input onto Imc neurons, and (3b) that in
parallel, Ipc, which influences activity across the layers of the OT, selectively spares the OT layer that provides
input to it (layer 10); revealing a precisely organized circuit design that minimizes runaway feedback excitation
in this network. We will test these hypotheses using in vivo electrophysiology and drug iontophoresis during
visual stimulus presentation in awake, head-fixed barn owls, together with computational modeling. Preliminary
data from the three aims support our hypotheses. Results from the proposed work have the power to reveal
fundamental neural circuit mechanisms involving multiple neurotransmitter systems for executing the
sophisticated computations that underlie stimulus competition and spatial selection across space.

Public health relevance
PROJECT NARRATIVE Selecting the most important information in a stimulus-rich world is a fundamental function that the brain must perform, and one that is essential to attention, decision-making, and perception. This proposal investigates the role of an evolutionarily conserved midbrain network in stimulus competition and spatial selection, with a focus on specialized cholinergic and inhibitory neurons within it. Results from this work will inform our understanding of how the brain processes complex sensory scenes and achieves stimulus selection, dysfunctions of which are associated with psychiatric disorders including ADHD, autism and schizophrenia.